Serograft: A bioinspired acellular biomaterial for combating tissue adhesions

PROJECT SUMMARY
Postoperative abdominal adhesions are a major economic and medical burden and remains a significant clinical
issue due to the lack of effective treatments. Estimates suggest more than 25% of laparotomy patients are re-
hospitalized due to formation of abdominal adhesions within 5 years of the initiating event, leading to annual
healthcare costs in the US upwards of $2.3 billion. Despite attention to this issue and the development of a
variety of commercially available treatments made from a variety of materials, these products are generally
considered only partially effective and there remains an unmet need for effective approaches to limit and prevent
postoperative adhesions. We have developed Serograft, a novel bio-inspired and bio-derived membrane to
reduce / eliminate formation of post-surgical abdominal adhesions. Serograft is a decellularized, regenerated
membrane derived from intestinal serosa and is thus composed of the same lubricating constituents found in
endogenous serosa – the native lubricating layer on visceral organs. Ex vivo testing indicates a significant
reduction in adhesion measured by shear test and a pilot study in induced abdominal adhesions in rats
demonstrated that Serograft outperforms both commercially available cellulose-based membranes and fibrin
patches on blinded scoring of degree of adhesion formation at 7 days post-op. This proposal will focus on the
further engineering of Serograft in a Janus format to achieve two overall goals: enhancement of anti-adhesive
properties on the peritoneal cavity-facing side of the material, and increased tissue adhesivity on the target
organ-facing side of the material. Aim 1 will focus on the development of porcine- and bovine- serosa-derived
variants of Serograft with conjugation to different forms and densities of poly(ethylene glycol) (PEG), to enhance
the anti-adhesive properties of the membrane. Aim 2 will focus on the Janus format of Serograft by incorporated
a chitosan methacrylate layer on one side of the material which will impart increased tissue adhesivity to the
target tissue in a wet environment. Both aims will employ ex vivo, in vitro, and in vivo studies to systematically
characterize the properties, performance, and biocompatibility of the materials. The success of the research is
supported by a strong, diverse team with complementary scientific expertise in biomaterials, inflammation and
tissue responses, and animal models with additional support from expert colorectal surgeons with extensive
clinical experience in the real-word relevance of the proposed application. Using the design-build-test
biomaterials development principles and well-established bioengineering methods, this proposal will leverage
the innovative and scientifically robust environment at Arizona State University and neighboring institutions to
develop a novel therapeutic intervention for abdominal adhesion prevention, with a strong path to clinical
translation.

Public health relevance
PROJECT NARRATIVE Postoperative adhesions, nonanatomic fibrous growths that disrupt normal tissue function and lead to a multitude of complications, are a major medical burden which occur in the majority (67-93%) of open abdominal surgeries. We developed Serograft, an acellular, regenerated serosal membrane which contains the overall architecture and growth factor composition of the natural lubricating layer of visceral organs – the serosa. The overall goals of this research are 1) to engineer porcine- and bovine-derived Serograft variants with enhanced non-adhesive properties, and 2) to develop Janus (i.e., two-sided) Serograft variants that are simultaneously highly adhesive on one side (to attach to wet visceral tissue surfaces) and minimally adhesive on the other side (to prevent adhesion formation) and to test these materials in multiple, mechanistically distinct models of abdominal adhesion in vivo in rats.